BIQSFP Study Supplemental Funding 2022

This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding
Program (BIQSFP) funding for the following SWOG Cancer Research Network studies: S1608,
S1803, S1827, S1929, S2114.
Additionally, this request contains the progress reports for the following additional studies:
S1314, S1500, S1602, S1612 and S1613.

Public health relevance
This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding Program (BIQSFP) funding for the following SWOG Cancer Research Network studies: S1608, S1803, S1827, S1929, S2114. Additionally, this request contains the progress reports for the following additional studies: S1314, S1500, S1602, S1612 and S1613.